2020 Cell Death Gordon Research Conference & Gordon Research Seminar

Abstract This proposal requests funds to help support the 2020 Gordon Research Conference (GRC) on Cell Death to be held June 14-19, 2020 and its associated Gordon Research Seminar (GRS) to be held June 13-14, 2020 at the Courtyard by Marriott in Shatin, Hong Kong. The Cell Death Gordon Conference is among the most highly regarded international conferences in the cell death community. Participants will give oral presentations, lead discussions or present their work in poster format. In keeping with the intimate spirit of the Gordon Conference, attendance will be limited, and presentations will feature unpublished work at the leading edge of this field. The overall goal of this conference is to expedite progress in cell death research and to use research findings for the development of new therapies. A secondary goal is to facilitate collaborations among cell death researchers and investigators in complementary basic, translational and clinical fields. The “Power Hour” during the GRC will provide a platform for women and under-represented minority groups to discuss challenges in the science community. The GRS target audience are students and postdoctoral trainees. The GRS provides trainees with the opportunity to present their work in a more peer-to-peer setting. The GRS will also have a few established faculties from industry and academia who will provide career counseling and advice to the trainees. We believe the GRS will provide the platform to help trainees launch their own independent research career. The aims of this conference are to: 1) gather established experts, junior scientists and researchers new to this field in a setting that supports structured and casual interactions, 2) promote exchange of cutting edge, innovative and unpublished science relevant to the roles of cell death in healthy and pathologic contexts, 3) expedite discoveries that advance mechanistic knowledge on cell death and facilitate clinical opportunities for the treatment and diagnosis of diseases caused by the dysregulation of this process. The major themes of the meeting will focus on: 1) Fundamental mechanisms of cell death, 2) Cell death in neuroinflammation and neurological disorders, 3) Non- canonical cell death, 4) Cell death in immunity, 5) Immunogenic cell death, 6) Harnessing cell death mechanisms in cancer, 7) Infectious diseases and cell death, and 8) Inflammation and tissue homeostasis. The meeting will facilitate the alignment of recent breakthrough discoveries with the development of new therapies for infections, immunological disorders, neuroinflammation and cancers.

Public health relevance
Project Narrative Excessive, reduced or inappropriate cell death often lead to inflammation and is frequently found in many diseases. The 2020 Gordon Research Conference and Gordon Research Seminar on Cell Death will provide a platform for unencumbered scientific exchange, focusing on mechanisms that specify cell death in normal immune responses in pathogen infection, neuroinflammation and cancer. The conference will foster career development of trainees at all levels, accelerate discovery in these areas, and advance new opportunities for therapeutic intervention in cell death-associated illnesses.